PTSomics - Machine Learning-Driven Discovery and Analysis of Polymorphic Toxin and Effector Systems

PROJECT SUMMARY/ABSTRACT
Bacterial protein toxins and effectors play a pivotal role in organismal conflicts, contributing significantly
to self/non-self recognition, bacteria-phage interactions, and the pathogenesis of bacterial diseases in human
and non-human animals, as well as commercially important plants impacting food security. Propelled by the
constant evolution of an arms race, these proteins and their associated components typically evolve rapidly
and display enormous diversity in terms of protein sequence, structure, domain architecture, and the
organization of their genomic loci (often referred to as virulence islands). The intricate complexity across
various levels has posed a formidable challenge for the identification and characterization of novel
toxin/effector systems and their biochemical mechanisms through conventional experimental and bioinformatic
approaches. Over the past decade, my research has made significant contribution in unraveling the
organizational and diversification principles governing several toxin/effector systems, encompassing both
protein domain architecture and genomic loci. Through the integration of these principles into a unique domain-
centric "guilt-by-association" analysis pipeline, I have successfully identified, unified, and categorized an
extensive array of known and novel toxin systems into a realm of polymorphic toxin and effector systems
(PTSs). This approach has enabled the dissection of hundreds of domains and the prediction of diverse
functions and activities for toxins/effectors, immunity proteins, and other associated components. Despite
these advancements, the ever-expanding genomic data highlights the presence of many undiscovered
systems, emphasizing the need for more sophisticated approaches to fully comprehend these complex
molecular mechanisms. In this proposal, my aim is to develop innovative machine learning (ML)-based
computational pipelines and resource for the systematic exploration and analysis of complex toxin/effector
systems. Additionally, I will leverage our unique analysis strategies to uncover novel toxin systems linked to
specific pathogens responsible for severe human and plant diseases, as well as crucial bacterial functions like
antiphage mechanisms and species competition.

Public health relevance
PROJECT NARRATIVE Polymorphic toxin and effector systems (PTSs) play a significant role in organismal conflicts, contributing to diseases in humans, animals, and plants. However, their rapid evolution and diverse characteristics make them challenging to study using traditional experimental and bioinformatics methods. This proposal seeks to address these challenges by developing a novel machine learning-based approach for identifying PTSs, establishing a specialized database and tools for comprehensive data mining and analysis, and uncovering novel systems associated with severe human and plant bacterial diseases, as well as essential bacterial functions like antiphage mechanisms and species competition.